Pathology of Mouse Models for Human Disease

DESCRIPTION (provided by applicant): This application asks for three years of support for the Annual Workshop on the Pathology of Mouse Models for Human Disease. The goal of this workshop is to provide an intense, high-level, interactive, week-long training session aimed at the next generation of veterinary and physician pathologists who will work directly (as PIs and collaborators) and indirectly (as support pathologists) in the development and characterization of mouse models of human disease. By keeping it small and intimate, with the faculty staying to interact with the attendees throughout much or all of the workshop, networks based on respect and familiarity will develop amongst the group, as has been the case in the past. Surrounding a highly productive and passionate core group of pathologists (the organizing team), we vary the program with a rotating group of pathology specialists and research scientists building from the staff of each host institution and thereby adding diversity and expertise using specialists from around the country and the world. The workshop will be held at The Jackson Laboratory on September 29th - October 5th, 2013, Cornell University in Ithaca (2014) and the University of Washington in Seattle (2015). Although we expect the format to be similar to that of previous workshops, we will continue to be responsive with regard to the emerging needs of the scientific community, as well as to advances in methods and technology. We plan to continue our policy of recruiting local talent from hosting institutions in order to keep the workshop fresh, but als opening up opportunities for graduates of our course who now are becoming prominent in the field of mouse pathology.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): The laboratory mouse is a powerful genetic tool that will continue to play a profound role in understanding the genetic basis and underlying biology of human disease, and in predicting clinical safety and efficacy of new and existing therapies. Training courses such as these are, and will continue to be, absolutely required to develop the cadre of highly skilled pathologists that will be needed to translate and compare pathobiology in mouse models and humans.